Building a mathematical problem-solving environment to prepare K-5 students for success in STEM and health careers.

Project Summary/Abstract
There is an enormous need for qualified people to pursue careers in STEM (Noonan,
2017). However, the lack of a strong foundation in mathematics means students are less likely
to pursue STEM majors and careers (Chen, 2013; Griffith, 2010; Huang, Taddese, & Walter, E,
2000; Kokkelenberg & Sinha, 2010; Lowell et. al., 2009; Seo, Shen & Alfaro, 2019). Students
from low-income families, women, and underrepresented minorities are also less likely to major
in STEM (Bettinger, 2010; Griffith, 2010; Hill, Corbett & Rose, 2010; Kokkelenberg & Sinha,
2010). Improving math learning in the elementary grades is important to ensure children have
the essential foundational skills and strong self-efficacy beliefs to be able to succeed with later
mathematics and pursue careers in STEM. With this Fast-Track grant, we propose to build a
mathematical problem-solving environment, Teachley Problem Solving (TPS), to transform the
way elementary students learn to solve math problems. TPS will include a set of digital tools to
help students understand and classify the underlying structure of problems, use clear visuals to
model the mathematics of the problems, and construct strong mathematical arguments. The
environment will also integrate into ASSISTments, a math curriculum platform built by The
ASSISTments Foundation and Wooster Polytechnic Institute .
Outcomes. The proposal will encourage two main outcomes, namely: 1) improved
student math achievement and 2) increased math self-efficacy. A key research aim is to
determine whether supporting elementary students with digital problem-solving tools helps them
develop stronger problem-solving skills as compared to typical instruction. We also anticipate
that using the engaging tools with real-time feedback will also bolster students’ motivation and
self-efficacy in mathematics.
Improving students’ academic outcomes and math self-efficacy during elementary school
will promote later success in high school mathematics. Since the number of advanced math
classes students take is correlated with likelihood to complete a STEM degree, (Chen, 2013) a
distal outcome of this proposal is increasing the number of students pursuing careers in STEM.

Public health relevance
Project Narrative There is an enormous need for students majoring in the fields of Science, Technology, Engineering and Mathematics (STEM), yet lacking a strong foundation in mathematics makes students, especially women, minorities and those from low-income backgrounds, less likely to pursue careers in STEM. Teachley Problem Solving will bolster students’ mathematics abilities, including mathematical reasoning, problem-solving and self-efficacy in the short and long term. This will, in turn, lead to several positive distal outcomes, such as increased STEM majors and careers.